Communication quality during family meetings in the intensive care unit: how does quality impact health outcomes?

Improving communication between healthcare professionals and family members is especially critical in high-stakes ICU environments where the need for shared decision-making demands that clinicians rapidly establish rapport and therapeutic alliance with family members of non-capacitated patients. Many well-designed trials testing ICU communication interventions have had negative or minimally impactful results, perhaps in part because we have only a rudimentary understanding of how social determinants of health (SDOH) – such as education/healthcare access, economic stability, and neighborhood environment– impact communication in the ICU. The goals of this R01 are to conduct a mediation analysis that will: 1) examine SDOH’s impact on communication between family members and ICU clinicians; 2) identify mechanisms of action related to how communication quality affects relationships with healthcare professionals and therapeutic alliance; and 3) determine how these factors contribute to or mediate outcomes for family members of ICU patients. This longitudinal, observational study will collect data from 320 family members from 5 ICUs in 3 states. Our primary health outcome is the provision of family-centered care (as measured by the Patient Perceptions of Patient Centeredness questionnaire- Family Version). Secondary health outcomes include family members’ psychological stress (anxiety, depression, symptoms of post-traumatic stress disorder) and measures of patient ICU utilization (e.g., ICU LOS, ventilator days). Mediating factors to be examined include communication quality and therapeutic alliance. Moderating factors include family members’ intrinsic traits (e.g., personality traits and decision-making style). We hypothesize that: 1) poor SDOH yield poor outcomes and result in less attention to family-centered care and worse ICU patient utilization outcomes; and 2) higher communication quality will improve the therapeutic relationship thus resulting in in improved attention to family-centered care and improved ICU patient utilization outcomes. Using our results, we will adapt a prominent conceptual model of communication to address the high-stakes communication needs of family members of ICU patients. Completing this work will advance the field by providing data to allow new understanding of how SDOH and other factors (e.g., communication quality) relate to provision of patient- and family-centered care. The knowledge gained will inform new content and concrete communication strategies for future ICU interventions aiming to facilitate high-quality communication and improve therapeutic alliances in pursuit of achieving patient- and family centered ICU care.

Public health relevance
There are many deficiencies in communication between intensive care unit (ICU) clinicians and family members. Understanding how social determinants of health (such as education/healthcare access, economic stability, and neighborhood environment) play a role in communication may help improve family members’ ICU experiences and patient outcomes. This project will collect data to examine how communication quality, social determinants of health, personality traits, and other factors play a role in how communication unfolds in the ICU and their impact on patient- and family-centered care. When the research is completed, we will have a better understanding of how these factors impact health outcomes that will help us to develop and tailor interventions that address these issues and may improve the relationship between clinicians and patients/families as well as patient- and family centered outcomes.